Comparative and cost effectiveness of diabetes medications

Background: Diabetes is a significant cause of cardiovascular disease (CVD), kidney and eye diseases, and
mortality. Diabetes and its complications also generate substantial healthcare utilization. Medications
contribute to both the benefits and costs of diabetes care. Newer diabetes medications have been developed
and marketed, but there remains a mismatch in our understanding of their net benefits, risks, and cost-
effectiveness. This is particularly relevant for older adults (≥65 years), where benefits and risks are more finely
balanced. Clinical practice guidelines recommend initial treatment with metformin across all age groups but are
unclear about next steps when metformin is ineffective. This is a frequent treatment transition. Medications
such as glucagon-like peptide-1 receptor agonists (GLP1) and sodium-glucose co-transporter-2 inhibitors
(SGLT2) have favorable effects on CVD and renal disease but also carry greater costs and side-effects. Within
VA, their usage is accelerating. It remains uncertain if these medications have specific advantages over the
frequently used generic medications, sulfonylureas (SU). Thus, we hypothesize that diabetes medication
usage is influenced by a complex interplay of patient factors and provider practice patterns. We further
hypothesize that when studied using real-world data, GLP1 and SGLT2 medications will reduce major adverse
outcomes and be cost-effective in comparison to SU when used as add-on treatment to metformin.
Significance: There are major gaps in the evidence base that informs clinical and cost-effective diabetes
treatment decisions among older Veterans (≥65 years), which comprise >70% of the VA diabetes cohort.
Innovation and Impact: We will employ a large nationwide sample of Veterans with diabetes who are dually
enrolled in VA/Medicare and apply advanced methods to reduce the impact of unmeasured factors. By using
real-world data, our study will add significant new information that informs the care of older Veterans, VA’s
diabetes and pharmacy programs, and clinical guidelines.
Specific Aims:
Aim 1. Determine prescribing patterns for SU, GLP1 and SGLT2. We will examine the extent to which patient
characteristics and clinician prescribing patterns influence initiating an SU, GLP1 or SGLT2 as add-on to
metformin.
Aim 2. Estimate the relationships between SU, GLP1, and SGLT2 usage as add-on to metformin with
healthcare utilization and adverse outcomes. Using clinician prescribing patterns as an instrumental variable,
we will measure the effects on emergency department (ED) visits, hospitalizations, healthcare costs,
hypoglycemia events, medication adherence, new diabetes complications and mortality.
Aim 3. Investigate the cost-effectiveness of initiating an SU, GLP1 or SGLT2 as add-on to metformin.
Methodology: This is a retrospective observational study of secondary data from patient-level administrative
and claims data from VA and Medicare, and uses a quasi-experimental design involving instrumental variables.
We will conduct the cost-effectiveness analyses using the IQVIA Core Diabetes Model (CDM) v9.0, which is a
well-validated Markov model.
Next Steps/Implementation:
We will collaborate with Pharmacy Benefits Management Academic Detailing Service (ADS) and VA Specialty
Care Services (SCC) throughout the project. At its completion we will work with ADS and SCC to develop
education and dissemination plans to inform front-line clinicians, specialty-care leads and VA policymakers.

Public health relevance
Diabetes is a common health condition among older Veterans. It is important for patients and their healthcare providers to understand the benefits and risks of diabetes medications. A particular area of uncertainty is when patients require additional treatment after an initial medication, metformin, is ineffective. This study advances diabetes care by studying the effects of generic and newer diabetes medications when added to metformin. We will use data from a large nationwide sample of Veterans 65 years and older and apply methods to carefully control for factors that may bias the results. The study will then compare three commonly used diabetes medications that may be added to the treatment regimen, and evaluate risks of mortality, diabetes complications, healthcare utilization, and cost effectiveness. This will ultimately help healthcare providers and patients make informed treatment decisions that align with patients’ unique circumstances and goals of care.